DEVELOPMENT OF TUMOR SEEKING PEPTIDE RECEPTOR RADIOPHARMACEUTICALS

Mass spectrometry analyses of peptides, or ligands synthesized in our laboratory are essential to confirm (or not) that the compounds are peptides and have the expected molecular weights. Confirmation by mass spectrometry will allow biological and other chemical studies to proceed.